Culturally Responsive Palliative Care Messaging for American Indians: An Efficacy Trial

Palliative care is specialized patient-/family-centered care designed to reduce suffering and
enhance quality of life for persons with serious illness. Culturally responsive palliative care can
ease serious illness burden experienced by American Indians (AIs) and improve seriously ill AIs
end-of-life decision-making. However, for seriously ill Northern Plains AIs, specifically those in
South Dakota (SD), access to and use of culturally responsive palliative care is severely limited.
To address this need, we will form a multidisciplinary, tribally-driven collaborative team
consisting of Great Plains Tribal Leaders Health Board, active AI community advisory boards at
the following reservations: Cheyenne River, Rosebud, and Pine Ridge, Massachusetts General
Hospital, and South Dakota State University. Our team will conduct a campaign messaging
efficacy test using the narrative as culture-centric health promotion model (NCHP) to create and
test culture-centric narrative messaging that improves knowledge of palliative care and
encourages participants to engage in formal and informal communication about palliative care.
The NCHP model is an evidence-based innovative approach to enhance AI’s knowledge and
intentions to talk formally and informally about palliative care, because it provides guidelines for
how to construct culture-centric narratives which identify the features of effective narratives and
the mechanisms by which the narratives work to transform cognitive and behavioral outcomes.
In Phase 1A of our project, we will conduct talking circles to elicit traditional health narratives. In
Phase 1B, those narratives will be transformed into culture-centric narrative health messaging.
In Phase 2A we will conduct a randomized trial to test the efficacy of the NCHP model for
increasing AI tribal members’ palliative care knowledge and intentions to discuss palliative care.
In Phase 2B, we will identify barriers and facilitators for implementation of the culture-centric
narrative messaging campaign to inform future scalable efforts. Our project aims to: 1) develop
culture-centric narrative messages to promote palliative care; 2) test the efficacy of culture-
centric narrative messaging about palliative care; 3) identify facilitators and barriers to campaign
implementation and sustainability. Data from this R21 will provide evidence for an R01 to
implement a messaging intervention with three AI tribes in SD, to increase palliative care
utilization. The approach of, and findings from, this study can also be used to develop culture-
centric messaging for different target groups, including the 500+ nationally recognized tribes in
the US, to improve AI's confidence using or recommending palliative care.

Public health relevance
Project Narrative/Public Health Relevance The purpose of our project is to create and examine the efficacy of culturally-responsive messages designed to encourage American Indians to discuss palliative care, using a community-based participatory research approach in conjunction with three tribes from South Dakota. Our long-term goal is to use these messages to develop a full-scale health communication campaign that measures the effects of the campaign on discussion about, and use of, palliative care among American Indian tribes within South Dakota and beyond. Our results benefit public health practice in American Indian communities by providing a framework for developing messages whose responsiveness to cultural values, beliefs, and practices strongly impact American Indians’ awareness and, use of, palliative care, thereby improving serious illness or end-of-life experiences.